2019 Congenital Muscle Disease Scientific Symposium

PROJECT(ABSTRACT ? 2019 Congenital Muscle Disease Scientific Symposium Cure CMD (Cure Congenital Muscular Dystrophy) seeks support from the National Institutes of Health to collaborate with aligned patient advocacy organizations A Foundation Building Strength (AFBS, focused on Nemaline Myopathy or NM) and Team Titin (focused on Titinopathy or TTN), in order to hold a two-part Scientific and Family Conference, to be held on July 25-28, 2019. Having recognized significant overlap in symptomatology, care management, and research communities, representatives from each organization believes they will benefit significantly from dialogue, information exchange, and collaboration. The ultimate aim is to accelerate progress toward clinical trials, treatments, and eventually, a cure for congenital muscle disease. Part one of the conference will be a Scientific Symposium (for which Cure CMD seeks support from the National Institutes of Health) that will include patient community representatives from each subtype; part two of the conference will be a Family Conference, wherein scientists will educate, learn from, and mingle with affected individuals and families. Key objectives are to: - Create, shape, and refine research projects and plans with clear patient input on need and design. At the conference, scientists working in congenital muscle disease will review proposed and current research projects and welcome challenges, support, and feedback from the scientific and patient communities; - Launch innovative, responsive research projects that reflect community needs, build on new collaborations, and engage the patient community; - Increase available care information to patients, caregivers, and clinicians, strategizing ways to avail valuable, life-changing care guidelines and strategies; and - Draft Subtype-Specific Plans for Research for the next three years, offering a roadmap to benefit the community; and - Ultimately, speed implementation of treatments and improve health outcomes. We believe collaboration is a critical step in speeding up practical knowledge and discoveries, and in utilizing evidence across the healthcare continuum. With a recently completed clinical trial in congenital muscular dystrophy declared a success, a natural history study for NM planned for launch in 2019, significant foundational research in TTN completed this year, and promising, relevant new research projects underway in all three conditions, this triad of collaborators—Cure CMD, A Foundation Building Strength (AFBS), and Team Titin— is eager to come together at this pivotal time in the story of congenital muscle disease.

Public health relevance
Rare disease groups often suffer common traits of lack of information and a slow rate of discovery and research; not only can this result in isolation, but also in poor health outcomes for the individuals living with such a disease. However, three closely aligned patient advocacy groups: Cure CMD, A Foundation Building Strength (AFBS), and Team Titin—having recognized significant overlap in symptomatology, care practices, and in their communities of researchers—aims to hold a collaborative conference that will, for the first time ever, welcome three separate but connected congenital muscle disease groups all working toward the same goal. The conference aims to create an opportunity for researchers to exchange information, spark dialogue, and launch new collaborations, ultimately contributing to better understanding of congenital muscle disease, creating better health outcomes, and serving as a model for other rare disease groups looking to build momentum toward treatments and a cure.